University of Iowa LURN Research Site

PROJECT SUMMARY/ABSTRACT
Lower urinary tract symptoms (LUTS) are common and have a significant negative impact on the
lives of adult men and women. The Symptoms of Lower Urinary Tract Dysfunction Research Network
(LURN) was formed in 2012 to address research gaps related to the care of patients with LUTS. The
long-term goals of the University of Iowa LURN Research Site are to better treat and prevent lower
urinary tract dysfunction in men and women. Toward this goal, additional research is required to
better characterize and understand clinically-useful LUTS patient subtypes and to better measure the
full patient experience related to the broad range of LUTS. The Iowa Research Site thus proposes to
perform multicenter and multidisciplinary research with other LURN sites to 1) Test and refine LURN
symptom-based clusters including a wider range of symptom severity and a wider range of
physiological measures than performed in prior studies, 2) Assess the relationship between physical
activity and sleep (important non-urologic factors related to LUTS) and LUTS and LUTS treatment
response, 3) Determine phenotypic characteristics of women with LUTS by measuring the functional
components via urodynamic testing, 4) Identify protein biomarker signatures contained within plasma
of specific subgroups of men and women with LUTS, and 5) Validate a comprehensive outcome tool
for men and women with LUTS. To address these aims, several distinct but complementary studies
are proposed. LURN will perform a 3-year cohort study of men and women with a diverse spectrum of
LUTS severity and characterize them with standardized clinical evaluations, self-reported symptoms
and associated conditions, quality of life, voiding diaries and detailed information on treatments and
treatment response over time. Wearable health tracking devices and smartphone text messaging
technologies will be utilized to collect objective physical activity and sleep quality data from cohort
study participants. Additionally, participants will complete the LURN Comprehensive Assessment of
Self-Reported Urinary Symptoms – Outcome Measure (CASUS-OM) to test its internal consistency,
validity and responsiveness to change after LUTS treatments. In another study, women with urgency
and urgency urinary incontinence will undergo a battery of standardized urodynamic tests focused on
sensory and motor functions of the urethra and bladder. Lastly, analysis of protein biomarker
signatures will be performed, using plasma samples previously collected from men and women with
LUTS. Important findings from these significant LURN research efforts will help improve the clinical
care of LUTS patients and will inform the development of future LUTS clinical studies.

Public health relevance
PROJECT NARRATIVE This project will help health care providers better identify patients with clinically important subtypes of lower urinary tract dysfunction with the goals of better understanding mechanisms of disease and of improving treatment outcomes. A valid, reliable and responsive outcome tool will also be developed for use by clinicians and researchers in assessing treatment response in patients with lower urinary tract symptoms.